Sleep-dependent negative overgeneralization in peri-pubertal anxiety

PROJECT SUMMARY
Sleep is increasingly understood as a critical contributor to brain health and development.
Problems with sleep are present in more than 90% of youth with anxiety, predict worsening
symptoms, and do not resolve following treatment-related remission of anxiety, leaving these
youth at ongoing risk (for review see McMakin et al., 2015). Yet, we have few testable models
for exactly how and why sleep-related problems impact mental health in young people, making it
hard to understand risk pathology and intervene with precision. Both sleep and anxiety are
heterogeneous and vary significantly across development, further complicating the picture.
Models that draw from the known roles of sleep for cognitive and affective functions (e.g.,
memory consolidation, emotion regulation) to explain how disruptions in these processes could
drive specific symptoms during sensitive periods of development are needed to move the field
forward. To this end, our ongoing R01 aims to test our theoretical model whereby disruptions in
key features of sleep neurophysiology (e.g., macro-arousals, spindle activity) impact emotional
reactivity and memory processing to drive negative overgeneralization (Aims 1 and 2). We also
examine whether this sleep-dependent process is modifiable (Aim 3). Despite methodological
complexity and a global pandemic, we are nearing completion of data collection for Aims 1 and
2 (96%; n=192/200) with results supporting key features of our model. The supplement is
requested to support the critical completion of Aim 3 (n=60) in which we turn our attention to
the potential to modify these processes. Specifically, we will use targeted memory reactivation
during sleep to manipulate which memories are selected for consolidation. If we can successfully
modify memory selection and this leads to changes in sleep microstructure coincident with a
reduction in negative overgeneralization, we will not only gain support for causality within our
model but also, we will be well-positioned for intervention work.

Public health relevance
PROJECT NARRATIVE The current proposal seeks funding to complete an ongoing R01 following Covid related impacts on facilities and data flow. The project focuses on anxiety in peri puberty as a high-stakes health problem and aims to deepen understanding of the symptom dimension of negative overgeneralization. We have found support for a model that describes how memory processes that are known to occur during sleep can go awry and affect neural mechanisms (pattern completion) that underlie negative overgeneralization. Support for our model suggests that processes that occur during sleep are central to the pathophysiology of anxiety. We are now seeking funding to complete our aim of testing whether it is possible to manipulate features of sleep to improve memory processing and related symptoms. This work can lead directly to interventions that leverage sleep neurophysiology to improve anxiety symptoms.